Developing mouse models to study circulating memory to Chlamydia infection

Chlamydia infections are a cause of blindness worldwide and a major cause of sexually transmitted disease in
the US. Greater understanding of protective immunity to Chlamydia at mucosal surfaces is urgently required if
an effective vaccine is to become a reality. This application will examine fundemental aspects of protective
CD4 T cells during infection of the female reproductive tract mucosa. Our experimental approach is unique in
that it utilizes a natural route of infection, uses an established model where CD4 T cells participate in bacterial
clearance, and allows for direct visualization of endogenous and transferred Chlamydia-specific CD4 T cells.
Our application specifically proposes to establish new mouse models to understand the mechanism of
protection mediated by circulating memory CD4 T cells and, (i) determine whether innate lymphoid cells recruit
memory cells to the FRT, (ii) examine the contribution of memory Th17 cells in coordinating bacterial
clearance. Developing these infection models and addressing these issues will expand our knowledge of
memory responses to Chlamydia and could be vitally important for the generation of a new vaccine for an
important human pathogen.

Public health relevance
The CDC estimates that Chlamydia is one of the most prevalent bacterial infections in the US and causes upper reproductive tract pathology in a growing number of otherwise health young women. Unfortunately, women with untreated Chlamydia infection can develop serious pelvic inflammatory disease (PID), infertility, chronic pelvic pain, or suffer from ectopic pregnancy. Given the high incidence of infection and the potential for serious pathology, the current consensus among scientists and clinicians is that an effective Chlamydia vaccine is needed. In order for a vaccine to be generated, we require a greater understanding of host immunity to Chlamydia infection in the upper reproductive tract. This application will utilize new antigen-specific reagents to study the mouse model of genital Chlamydia infection. We will use these reagents to examine the mechanism of circulating memory to Chlamydia in the female reproductive tract.